Development of a Novel Vasorelaxing Peptide

PROJECT SUMMARY
Reduced nitric oxide (NO) availability is a common pathophysiological feature of many cardiovascular
diseases. While NO donors are used, significant issues limit their utility, including the development of nitrate
tolerance and endothelial dysfunction. Although intermittent nitrate therapy is common practice, this strategy has
limitations and is not considered a solution to nitrate tolerance issues. Extensive intravenous use of sodium
nitroprusside is associated with a risk for cyanide poisoning. There is thus a strong need to identify new
approaches to promote endogenous NO production. The stromal interaction molecule 1 (STIM1), a Ca2+-sensing
protein in the endoplasmic reticulum (ER), is a critical determinant of store-operated Ca2+ entry, which in
endothelial cells (ECs) is required for sustained endogenous NO production. Vascular smooth muscle-specific
STIM1 deletion blunted hypertension and cardiac hypertrophy caused by angiotensin II. In contrast, endothelial
STIM1 is predictably important for vasorelaxation, such that EC-specific STIM1 deletion attenuates endothelium-
dependent vasodilation and increases blood pressure. However, no strategy currently exists to directly target
endothelial STIM1 for clinical benefit.
In this application, we propose to develop a novel vasorelaxing peptide (EFG2) that acts by promoting
endogenous NO production and has several unique properties that are of potential clinical benefit. Our peptide
is derived from the G protein-coupled estrogen receptor, is designed to be specific for the endothelium, and
directly targets STIM1 to trigger endothelial Ca2+ entry without depleting ER Ca2+ store, thereby stimulating
endogenous NO production while protecting ER function. Our objectives in this proposal are to delineate the
mechanisms of action of EFG2 in endothelial cells, assess its effects on several aspects of EC function, begin
testing its potential as a vasorelaxing agent using a model of hypertension, and through these studies, provide
training for students in the graduate and medical programs at DMU. Three specific aims are proposed. AIM 1
will delineate the mechanisms of action of EFG2 in endothelial cells, by testing its ability to activate the
prototypical ICRAC current and document its target domains on STIM1 that are responsible for its effect to trigger
endothelial Ca2+ entry. AIM 2 will assess the effects of EFG2 on several aspects of EC function, by testing the
hypotheses that EFG2 promotes eNOS activity, reduces inflammation-induced expression of vascular adhesion
molecules and smooth muscle proliferation, but does not cause ER stress. AIM 3 will test the hypothesis that
EFG2 reduces blood pressure in hypertensive rats in a NO-dependent fashion.
Completion of the studies will introduce a mechanistically novel vasorelaxing peptide with several unique
features that are of potential clinical benefit, provide quality student training, and enhance overall research
outcomes of Des Moines University.

Public health relevance
PROJECT NARRATIVE Reduced nitric oxide availability is a key factor in the pathophysiology of many cardiovascular diseases. While nitric oxide donors are used in practice, nitrate tolerance and development of endothelial dysfunction limit their clinical efficacy. In this project, we will develop a novel peptide that promotes endogenous production of nitric oxide through a unique mechanism of action leading to vasorelaxation and anti-inflammatory effects while protecting endothelial cell function.